Wyoming IDeA Networks for Biomedical Research Excellence Phase 4

Project Summary
The Wyoming INBRE Data Science Core will develop a cloud-based learning module for the
Sandbox that will be of beneﬁt to those interested in gaining more insights into genomics
data sets. The module will add a Sandbox learning pathway that provides IDeA network
members training in the wide-ranging and impactful use of RADseq data for studies
focused on population genetics, linkage mapping, genome-wide association studies,
conservation genetics, evolutionary biology, and crop/livestock improvement. The module
will provide the IDeA community an introductory learning module aimed at increasing
cloud literacy and demonstrating the power of RADseq datasets to answer important
biological questions.

Public health relevance
The Wyoming INBRE Building Cloud-based Learning Module project will contribute to the NIH IDeA goal of training students and investigators how to access and analyze large and complex datasets. This project will focus on training in the wide-ranging and impactful use of RADseq data and demonstrating the power of RADseq datasets to answer important biological questions.